Glucose/lipid metabolism and vessel development in phase I ROP

ROP, a leading cause of blindness in children, afflicts ~16,000 premature infants yearly in the US1. ROP
incidence is increasing because of more in vitro fertilization resulting in more multiple births with lower birth
weight. Also, increasingly low gestational age infants survive. Oxygen is supplemented at higher levels with
more ROP. Current ROP treatments (laser photocoagulation and anti-VEGF therapy) are not always effective,
and long-term anti-VEGF therapy may potentially impair brain and organ development. We need to find ways
to treat early to prevent phase I ROP, and thus prevent neovascularization. Hyperglycemia and associated
dyslipidemia, commonly see in preterm infants and associated with ROP development, may contribute to
vessel loss in phase I ROP. We must understand the mechanism to develop safe and effective treatment for
early ROP to prevent late phase II neovascularization. We preliminarily found that fibroblast growth factor 21
(FGF21), a significant glucose/lipid metabolic modulator, prevents retinal vascular delay in a mouse model of
phase I ROP. Therefore, we propose that
In dyslipidemia/hyperglycemia-exacerbated phase I ROP, FGF21 improves glucose/lipid
metabolism and vessel development.
In the mouse model of ROP with neonatal metabolic dysfunction (NMD-ROP), we will examine if 1) FGF21
improves retinal vascular development; 2) FGF21 effect on lipid/glucose metabolism; 3) does FGF21 promote
normal vascularization by regulating glial cell metabolism and angiogenic factors.
This study will determine 1) the role of FGF21 in a novel mouse model of hyperglycemia-exacerbated phase I
ROP; 2) the metabolic impact of FGF21 on retinal lipid and glucose use; 3) the role of retinal glial cell
metabolism in supporting retinal vessel growth. FGF21 may prevent and treat ROP at an early stage.

Public health relevance
We will examine if FGF21 protects against retinal vascular development delay in NMD-ROP mice, and examine if retinal glial cell metabolism contributes to this process; little work has been done in this area. We have preliminarily found a profound beneficial effect of FGF21 on retinal vessel growth in the mouse model of NMD-ROP. FGF21 administration may prevent and treat ROP at early stage.